Building a causal pathway framework to identify interventions to eliminate racial/ethnic disparities in severe maternal morbidity

ABSTRACT
The US is in the midst of a maternal health crisis. The US has worse maternal mortality (MM) than any
other high-income country and is the only one for which the rate is increasing. Severe maternal morbidity
(SMM), which encompasses conditions that put pregnant women most at risk of dying, doubled in the last
two decades. Women of color, especially Black and Native American women, are at 2-3-fold or greater
increased risk of these outcomes. This proposal focuses on SMM, as a sentinel outcome leading to MM,
yet 100 times more common. Most prior research on SMM has focused on proximal clinical factors
(primarily related to co-morbidities and obstetric management); these factors alone are insufficient for
explaining SMM or its racial/ethnic disparities. The objectives of this proposal are: 1) develop a causal
pathway framework to understand how social determinants and more proximal health-related factors
together contribute to SMM risk and disparities, and 2) use this framework to identify actionable strategies
to reverse current trends and eliminate inequities. We will create a unique dataset that harmonizes 4
years of data from 6 states on 4.4 million births and 66,000 women with SMM. These states collectively
include 1 in 4 US births and sufficiently diverse social environments to disentangle complex multi-level drivers
of maternal health inequity. Our focus is on social determinants from 4 specific domains: socioeconomic
disadvantage, structural inequality, community resources, and health care access, characterized at the
county, neighborhood (census tract or ZIP code), and individual level. Health-related intermediaries
include birth hospital quality of care, mode of birth, and maternal morbidities (eg, hypertension, anemia).
These domains and intermediaries were selected for their relevance to racial/ethnic disparities in
maternal health. In addition, we will evaluate impacts of 3 Quality Improvement (QI) collaboratives on
SMM disparities, which were designed to improve specific aspects of hospital quality of care and
implemented by state-wide perinatal quality collaboratives (PQCs) in 3 of the 6 states included in this
proposal. Our Specific Aims are: 1) Assess the relative and joint contributions of multi-level social
determinants to SMM and SMM disparities; 2) Identify potential health-related mechanisms by which
multi-level social determinants affect SMM and SMM disparities by conducting causal pathway analyses;
and 3) Evaluate the impact of 3 QI collaboratives designed to reduce SMM, on racial/ethnic disparities in SMM
(3a), and apply the causal framework developed in Aims 1 and 2 to these state-specific contexts, to identify
state-specific strategies for addressing SMM disparities (3b). We currently have very limited understanding of
how social determinants contribute to SMM or its disparities. The proposed research will fill this important
knowledge gap, which is an essential part of realizing sustainable improvement of maternal health and
elimination of racial/ethnic disparities.

Public health relevance
NARRATIVE The objectives of the proposed research are to build a causal pathway framework that helps us understand how multi-level social determinants and intermediary factors related to health and quality of health care together lead to severe maternal morbidity and its disparities. We will use this framework to analyze population-level data from multiple states. Our findings will enable us to identify actionable strategies to prevent this life-threatening outcome and promote equity in maternal health.